Integrative Machine Learning for Common Fund Spatial Omics

PROJECT SUMMARY / ABSTRACT
The NIH Common Fund supports transformative programs that generate large-scale datasets crucial for the
broad biomedical research community. The emerging spatial transcriptomics in Common Fund programs
provide invaluable insights into cellular diversity and tissue organization. However, integrating and analyzing
these diverse datasets remains a significant challenge. To address this gap, we propose developing new
machine learning methods to analyze spatial transcriptome data from multiple NIH Common Fund programs, in
particular, HuBMAP and SenNet. First, we will develop machine learning methods for integrative analysis of
multiple spatial transcriptome datasets. This will include creating a scalable, platform-agnostic framework using
pretrained single-cell RNA-seq foundation models to integrate diverse spatial transcriptome datasets and a
method to analyze spatial gene programs across multiple samples. Second, we will develop machine learning
methods to reveal the underlying mechanisms of spatial gene expression. This will involve creating a
transformer-inspired model to disentangle intrinsic cellular factors from intercellular interactions and a
framework to identify transcription factors modulating spatial gene programs. Collectively, the methods and
tools developed in this project will significantly enhance the utility of existing NIH Common Fund spatial
transcriptomics datasets and facilitate integration with other related programs. This will drive forward our
understanding of spatial gene regulation and its role in health and disease, aligning with the NIH Common
Fund’s mission to support transformative research with broad scientific impact.

Public health relevance
PROJECT NARRATIVE The proposed work is relevant to public health because it will help enhance our understanding of cellular diversity and tissue organization. Because we develop generalizable tools, we will also bring our methods and results to bear on a broad range of ongoing health related research. Thus, the proposed project is relevant to NIH’s mission that seeks to obtain fundamental knowledge that will help to improve human health.